The gene regulatory landscape of healthy and failed repair proximal tubule subpopulations in kidney disease

Chronic kidney disease (CKD) has an immense burden on healthcare, with a prevalence of 37 million in the
American population. Untreated CKD leads to fibrosis and declining renal function until a patient requires life-
sustaining renal replacement therapy, so there is a critical need for treatment options to halt or reverse the
progression of disease. My lab has characterized a pro-inflammatory cell type, originating from the failed repair
of injured proximal tubule (FR-PT) cells, that correlates with failed recovery from acute kidney injury (AKI) and
subsequent transition to CKD. Single cell RNA and ATAC sequencing of human adult kidney samples has
provided evidence for this cell state’s presence in kidneys that have not experienced AKI. As such the FR-PT
cell could represent a convergence point for acute and chronic renal injury through which progressive
inflammatory and fibrotic signals are perpetuated, leading to CKD progression. A treatment that inhibits or
reverses transition to a failed repair state could ameliorate CKD outcomes by reducing the FR-PT cell
population responsible for continued pro-inflammatory and pro-fibrotic signaling. Since FR-PT cells appear to
be a distinct population from healthy proximal tubule (PT) cells, gene regulatory mechanisms may be an
important contributing factor to the formation of FR-PT cells. This project will reveal the gene regulatory
networks and regulatory elements underpinning development of the FR-PT cell population through analysis of
a single cell multiomic dataset generated by integrating single cell RNA-seq and ATAC-seq profiles of adult
human kidney, specifically focusing on characterizing transcriptional and epigenetic differences between
healthy PT and FR-PT cells. This dataset will be used to train a parametric gene regulatory network model for
PT cells to identify candidate cis- and trans-regulatory elements involved in the transition between healthy and
failed repair PT states. This will be followed by experimental validation of the identified regulatory elements to
confirm their predicted role. This proposal aims to identify therapeutic candidates targeting FR-PT cells as a
driver of CKD progression, addressing an outstanding need for better CKD therapies. Completion of this
project will also help me achieve my training goals to expand my scientific knowledge, learn to identify and
study translatable research questions, and gain experience with bioinformatics and single cell techniques. Dr.
Benjamin Humphreys is a model physician-scientist for these goals, and his laboratory is an optimal
environment for this project and my training goals, because of his research group’s single cell expertise and
the lab’s excellent training and collaborative atmosphere. Successful completion of this project will contribute a
better understanding of CKD and possible treatment strategies and will prepare me to pursue a career as an
independent physician-scientist.

Public health relevance
Despite the immense health burden of chronic kidney disease, effective treatment options remain limited. A distinct proximal tubule subpopulation may drive chronic kidney disease progression, so a better understanding of the formation of this subpopulation may lead to clinical breakthroughs. This project aims to identify regulatory elements mediating proximal tubule state transitions that may be therapeutically targetable.